The National Spina Bifida Patient Registry at the University of Pittsburgh

APPLICATION FOR FEDERAL ASSISTANCE
SF 424 (R&R)
3. DATE RECEIVED BY STATE
0MB Number: 4040-0001
Exoiration Date: 10/31/2019
State Application Identifier
1. TYPE OF SUBMISSION
[ ] Pre-application [XI Application [ ] Changed/Corrected Application
2. DATE SUBMITTED
Appllcant Identifier
4. a. Federal Identifier
b. Agency Routing
Identifier
c. Previous Grants.gov
Tracking ID
5. APPLICANT INFORMATION
Legal Name: University of Pittsburgh
Department: Office of Research
Street 1: 123 University Place
Street 2: 821 University Club
City: Pittsburgh
State: PA: Pennsylvania
Country: USA: UNITED STATES
Organizational DUNS: 004514360
Division:
County/Parish:
Province:
ZIP/ Postal Code: 15213-2303
Person to be contacted on inatters involving this application
Prefix: First Name: Jennifer Middle Name: E.
Last Name: Woodward Suffix:
PosltionfTitle: Vice Chancellor for Research Operations
Street 1: 123 University Place
Street 2: B21 University Club
City: Pittsburgh County/Parish:
State: PA: Pennsylvania Province:
Country: USA: UNITED STATES ZIP/ Postal Code: 15213-2303
Phone Number: 412-624-7400 Fax Number:
Email: [email]
6. EMPLOYER IDENTIFICATION (E/N) or (TIN): 125-0965591 A6
7. TYPE OF APPLICANT: X: Other (specify)
other (Specify): Private, non-profit, state-related, educ inst
Small Business Organization Type [ J Women Owned [ ] Socially and Economically Disadvantaged
8. TYPE OF APPLICATION:
[XI New [ ] Resubmission
[ ] Renewal [ ] Continuation [ ] Revision
If Revision, mark appropriate box(es).
[ ] A. Increase Award [ ] B. Decrease Award [ ] C. Increase Duration [ ] D. Decrease
Duration
I I E, Other (specify):
Is this application being submitted to other agencies? Yes 11 No [XI What other Agencies?
9. NAME OF FEDERAL AGENCY: 110. CATALOG OF FEDERAL DOMESTIC ASSISTANCE NUMBER: 93.315
Centers for Disease Control and Prevention - ERA TITLE: Rare Disorders: Research, Surveillance, Health Promotion, and Education
11. DESCRIPTIVE TITLE OF APPLICANT'S PROJECT:
The National Spina Bifida Patient Registry at the University of Pittsburgh
12. PROPOSED PROJECT:
Start Date Ending Date
09/01/2019 08/31/2024
13. CONGRESSIONAL DISTRICT OF APPLICANT
PA-018